CENTRALIZED CHEMOPREVENTIVE AGENT REPOSITORY AND CHEMISTRY SUPPORT

The purpose of this requirement is to continue an established Repository program within the Division of Cancer
Prevention (DCP) at the National Cancer Institute (NCI). The successful Contractor shall maintain a centralized
source of agents, and development services necessary to support chemoprevention studies for effective medical
interventions in the prevention or reduction of cancer. The Contractor shall maintain the repository which provides
important logistic organization for the acquisition, tracking, storage, maintenance, testing, quality control, and
distribution of investigational agents.